Removing Barriers to Fluoride Varnish Application in Primary Care Settings (Supplement)

Removing Barriers to Fluoride Varnish Application in Primary Care Settings
(Supplement)
Project Summary/Abstract: Dental decay is an important, ongoing public health concern
that impacts children from low-income households and from racial and ethnic minorities at
higher rates than the general population. Because young children are much more likely to visit a
primary care provider (PCP) than a dentist, including appropriate and effective preventive oral
health services (POHS) at pediatric well-child visits has the potential to dramatically improve
children’s oral health. Fluoride varnish (FV) application is one such POHS that is reimbursed by
insurance programs in the primary care setting for younger children, yet only a small proportion
of physicians apply FV. Federally Qualified Health Centers (FQHCs) play a vital role in reaching
populations that experience health disparities. In this supplement, we propose to expand the
scope of our original R15 AREA grant ‘Removing Barriers to Fluoride Varnish (FV) Application in
Primary Care Settings’ by studying FQHCs in greater depth.
The Specific Aims for this administrative supplement to address preventive interventions
with populations that experience health disparities include: Aim 1: Understand the program level
challenges and status of FV integration during well visits in FQHC clinics. Surveys of PCPs at
FQHC clinics across Georgia will yield quantitative data that will elucidate the status of FV
delivery at the individual FQHCs and provide insights on program level challenges to FV
implementation. Aim 2: Assess barriers and facilitators to FQHC FV integration and
implementation at the organizational level. Guided by the Consolidated Framework for
Implementation Research (CFIR), FQHC directors will be interviewed to understand their
perceptions of the factors that either impede or facilitate the integration of FV application in the
FQHC setting. Aim 3: Complete workflow modeling and analysis for FQHCs. Workflow maps
that can be the starting point for FQHCs to understand how FV application can fit into the well-
visit, will be built and assessed. These will enhance the R15 Aim 3 simulation model.
The objective of this study is to assess and reduce barriers currently dissuading FQHC
PCPs from providing FV during well-child visits. The overall research contribution will be specific
workflow suggestions and resulting resource and cost data, as well as a better understanding of
barriers and facilitators to implementation, that will allow physicians’ offices to make decisions
on how to integrate FV in their pediatric well-child visits based on their own unique practice
characteristics. These improved frameworks, widely disseminated, will facilitate more
widespread delivery of POHS and reduce health disparities in preventive care.

Public health relevance
Project Narrative: Despite demonstrated effectiveness of fluoride varnish (FV) application in reducing dental decay, and insurance reimbursements available for primary care providers (PCPs) in all states, few PCPs currently offer FV to their eligible patients. The proposed research is highly relevant to public health because the study findings will help interested PCPs, including those from Federally Qualified Health Centers specifically, to integrate FV into their well-child visit workflow efficiently, effectively increasing the number of young children who receive preventive oral health services and reducing health disparities in preventive care receipt.